Global Epidemiology of Infectious Diseases

Project Summary/Abstract
Our training program recruits diverse postdoctoral fellows, predominately physicians, and develops their skills
to conduct infectious disease epidemiology research. The program stresses epidemiology as a key tool to face
growing infectious disease threats. It highlights the global epidemiology of infectious disease, because the
increased connectivity of human populations means that the epidemiology and control of infectious diseases
requires a global perspective. The program will be interdisciplinary, engaging 29 faculty research mentors from
seven Departments (Medicine, Pediatrics, Epidemiology, Biology, Pathology and Microbiology, Immunology
and Civil and Environmental Engineering). Three trainees per year will be drawn from candidates for the
Infectious Diseases Fellowship Programs in Pediatrics and Internal Medicine; exceptional applicants from other
postdoctoral programs at Stanford may be considered if they have demonstrated prior commitment to
Infectious Diseases epidemiologic research. Trainees will conduct research under the mentorship of a program
faculty member committed to trainee success. Research is expected to be cross-disciplinary to take advantage
of the breadth of campus faculty and the varied exceptional research expertise available at Stanford. To
promote interaction among trainees and faculty we will convene research seminars conducted by trainees;
interdisciplinary seminars in infectious diseases epidemiology; weekly infectious diseases grand rounds;
lectures on infectious diseases, ecology and risks; and an annual one-day research retreat. Each trainee will
be counseled by a Research Committee comprised of their mentors and others with expertise relevant to the
research and to individual career goals. At least twice a year, trainees will meet with their mentors and the
program directors to discuss their Professional Development Plan. In addition, as part of this T32 renewal, we
propose to increase our emphasis on epidemiologic methods including requiring that all fellows supported by
the training grant complete four courses taught by the Department of Epidemiology in global infectious disease
epidemiology and modeling. This classroom instruction will complement the in-depth mentored research
experience so that trainees will develop both the content expertise and applied skills critical to become
independent researchers. All trainees will be strongly encouraged to apply for independent support. Trainees
will be appointed to the program for a year at a time. They will spend between 1 and 3 years in the program.
We envision that graduates of this program will assume independent research or public health leadership
positions and engage in careers that address the great infectious disease threats of their generation.

Public health relevance
Project Narrative Despite remarkable progress in reducing mortality from infectious diseases during the 20th century, in 2020 humanity faces three major growing infectious disease threats: 1) emerging infections; 2) antimicrobial resistance; and 3) synthetic pathogens. Well trained epidemiologists are critical to inform and guide the societal response to these worsening and unprecedented threats. This infectious disease epidemiology training program will produce researchers with the skills necessary to confront these 21st century threats.